Differentiated interventions to support HIV PrEP persistence in patients with substance use

ABSTRACT/PROJECT SUMMARY Dr. Hojilla's long-term career goal is to become an independently funded investigator with expertise in HIV prevention and precision behavioral interventions to optimize biomedical prevention strategies, like pre- exposure prophylaxis (PrEP), in populations with substance use (SU). PrEP is a key pillar of the Ending the Epidemic Initiative and although uptake is increasing, the high rates of PrEP discontinuation threaten its public health impact. SU, including drug and unhealthy alcohol use, are well-established predictors of HIV risk and presents an overlapping vulnerability for poor adherence and poor retention in care. Early PrEP discontinuation is a key predictor of subsequent HIV infection, but few persistence interventions exist, particularly for individuals with SU. Differentiated interventions, where efforts are adapted based on individual needs, have shown promising findings in the HIV treatment literature, but have not been evaluated in the context of PrEP. Using the ADAPT-ITT framework, the overall objective of this K23 application is to adapt existing evidence- based adherence strategies to develop differentiated PrEP persistence interventions in populations with SU. The study will leverage a large, clinic-based cohort of PrEP patients in Kaiser Permanente Northern California (KPNC), an integrated healthcare delivery system. Aim 1 will estimate individual growth trajectories to identify latent patterns (classes) of PrEP persistence. We will evaluate predictors of each class and compare differences in patterns of PrEP use between patients with and without SU. Understanding the patterns by which patients use PrEP over time and the characteristics that predict problematic patterns of PrEP use will allow us to distinguish individuals who require intervention and evaluate what interventions will work best for a given subgroup. In Aim 2, patients with SU from the two persistence classes with the highest rates of PrEP discontinuation will be selected for qualitative interviews to examine intervention preferences and barriers and facilitators of sustained PrEP use within each subgroup. Clinician stakeholders will also be interviewed to assess capacity to provide differentiated interventions. In Aim 3, evidence-based adherence strategies will be identified and adapted based on qualitative insights from Aim 2. An intervention protocol will be developed, iteratively revised with input from topical experts, and piloted to assess feasibility and acceptability. Findings will inform the development of a future efficacy trial. The proposed research and training plan will provide Dr. Hojilla with the necessary skillset to achieve his long-term career goal. He will gain training in 1) advanced quantitative analytical approaches to estimate longitudinal growth trajectories; 2) qualitative research methods to understand stakeholder needs; and 3) intervention adaptation to develop tailored strategies. He will be supported by a multidisciplinary team of mentors at the University of California, San Francisco (UCSF) and the KPNC Division of Research. Dr. Hojilla's training will prepare him to lead high-impact research evaluating precision behavioral interventions to optimize HIV prevention strategies, such as PrEP, in populations with SU.

Public health relevance
PROJECT NARRATIVE Leveraging electronic health record data from a large cohort of PrEP patients, the proposed study will identify latent classes of PrEP persistence among patients with substance use. Findings will identify latent subgroups at increased risk for poor PrEP outcomes and the characteristics that predict problematic patterns of PrEP use. These results will inform the development of differentiated behavioral interventions to support sustained PrEP use in substance-using populations who are at increased risk for HIV and for falling out of PrEP care.